Mitophagy and Cardiac Myocyte Protein Aggregation

Cardiac myocyte protein quality control is critical for maintenance of the contractile apparatus and cardiac
function. Mutations in chaperone proteins that affect protein quality control induce proteotoxicity, sarcomere
dysfunction and cardiac myocyte cell death. One such point mutation in the CRYAB gene in humans, results in
an arginine to glycine change at position 120 in the heat-shock protein beta-5 (R120G HSPB5) protein, and
provokes autosomal dominant cardiomyopathy resulting in heart failure, need for cardiac transplantation and
premature mortality. Strategies to prevent proteotoxicity have focused on stimulating the autophagy-lysosome
pathway to remove protein aggregates; and need to be refined for maximizing therapeutic benefit. Our studies
during the current grant-funding period have uncovered an essential role for TRAF2, an innate immunity
protein, in mediating basal mitophagy in cardiac myocytes. Our preliminary data show that loss of mitophagy
with TRAF2 ablation in cardiac myocytes induces marked protein aggregation in cardiac myocytes, despite a
lack of effect on general macro-autophagy. In a mouse model of cardiac myocyte specific human HSPB5
R120G mutant protein expression, we have uncovered evidence for mitochondrial accumulation of HSPB5
protein, along with polyubiquitinated proteins and p62 (an adaptor protein essential for aggregate formation).
This is accompanied with markedly increased TRAF2 expression in the mitochondria and reduced
mitochondrial protein content, pointing to a role for mitophagy in handling protein aggregate pathology. Given
recent observations in yeast and mammalian cell lines indicating that mitochondria may facilitate uptake and
degradation of cytosolic protein aggregates, we hypothesize that mitophagy facilitates removal of cytosolic
protein aggregates of HSPB5 R120G mutant protein in cardiac myocytes to prevent cardiac myocyte death
and cardiomyopathy. In this renewal application, we have generated reagents and developed collaborations to
test this hypothesis via the following aims. In aim 1, we will examine if mitophagy is required for removal of
protein aggregates in mice. Studies will also be performed in human induced pluripotent stem cell-derived
cardiac myocytes (iPSC-CMs) with CRISPR targeted ablation of TRAF2, and in those with CRISPR-knock-in of
R120G mutation. In aim 2, we will examine if TRAF2-induced mitophagy is sufficient to facilitate removal of
protein aggregates in mice and in human iPSC-CMs. Aim 3 will focus on mechanistic studies to understand the
steps involved in mitochondrial uptake of HSPB5 R120G mutant protein uptake in mitochondria. Studies in
mice will focus on impairing p62-mediated protein aggregation to examine the role of p62 in mitochondrial
protein aggregate uptake. Experiments in yeast and mouse model systems will examine if hsp104, a yeast
disaggregase protein shown to be functional in mammalian cells, is required and sufficient for mitochondrial
protein aggregate uptake, respectively. These studies will determine the role of mitophagy in cytosolic protein
quality control, and efficacy of therapeutically harnessing this pathway to treat proteotoxic cardiomyopathy.

Public health relevance
Cardiac muscle cells have highly specialized pathways to ensure the quality of muscle proteins that are required for contraction. Genetic mutations that impair key proteins in these pathways, are implicated in causing human cardiac muscle weakness resulting in heart failure and premature death. In this proposal, we examine the mechanisms for development of cardiomyopathy by one such mutation, namely R120G in a chaperone protein, alpha-B crystallin (HSPB5), to understand the efficacy of stimulating autophagic pathways for mitochondrial quality control in preventing protein aggregates and cardiomyopathy.